NH PHL Discipline C Rad Chem Analytical Track 1 - Food Defense

Discipline C: Radiochemistry Analytical Track 1: Food Defense The NH PHL plans to prove presence or absence of radioactive contamination and determine the identities of radionuclides present in human or animal food samples through screening. The data generated by the NH PHL will be used to characterize the extent of food contamination, for following trends, and for calculating intake and to triage data to determine whether further analysis is needed. Semi-quantitative results will be used to determine if contamination is within regulatory limits. NH PHL is ready and able to perform analyses of human or animal food for the detection of gamma emitters, for example: Cs-137 and I-131. The NH PHL is also prepared to detect alpha emitters (Am-241 and Pu-239) and beta emitters (Sr-90) for food defense. All equipment is verified to be in working order and reagents and supplies are available. All analysts are trained annually and demonstrate competency in all testing activates performed. The NH PHL will participate in FDA-requested triage exercises, and/or surveillance activities to support and maintain readiness as well as participate in national security event exercises, as requested.

Public health relevance
Project Narrative - Discipline C: Radiochemistry - Analytical Track 1: Food Defense The New Hampshire Public Health Laboratories (NH PHL) will support laboratory surge capacity for the analysis of foods and food products for the presence/absence of radioactive contamination. The activities of the NH PHL will enhance the Food Emergency Response Laboratory Network capacity and readiness to provide the identities of radionuclides present in animal or food contamination to support a fully integrated food safety system.